2025 Inaugural Cholestatic Liver Disease Summit

PROJECT SUMMARY
The Inaugural Cholestatic Liver Disease Summit will be held June 26-27, 2025 at Children’s Hospital Colorado
and the Hyatt Regency Hotel in Denver, CO. The concept for this Cholestatic Liver Disease Summit was
developed through a collaboration between three 501c3 nonprofit patient advocacy organizations in the
cholestatic liver disease space – BARE Inc. (biliary atresia), PFIC Network (progressive familial intrahepatic
cholestasis) and ALGSA (Alagille Syndrome Alliance). This event will be held in connection with family
conferences held by these 3 organizations, allowing for free interaction and exchange of ideas between
clinicians, scientists, patients and families. The 2025 Cholestatic Liver Disease Summit will address an unmet
need in the scientific and clinical communities, both academic and industrial, by focusing on the common
pathophysiology, models for study, and therapeutic challenges met by academic and industry practitioners in the
field. We plan to use the program of this meeting to mix speakers representing diverse areas of cholangiocyte
and hepatocyte biology, in clinical, basic and translational research, to foster networking opportunities and
generate a platform for open discussion regarding the scientific and therapeutic challenges unique to this field.
The goal will be realized by bringing together 1) clinicians that treat patients with pediatric cholestatic liver
diseases, 2) investigators that focus on mechanistic aspects of bile duct development, hepatocyte canalicular
development, cholestasis and cholangiopathies, 3) industry partners interested in the rare disease space, and
4) patients, families, caretakers, and patient advocates. Our goal is to not only disseminate cutting edge
information to patients, advocates, clinicians, scientists and industry representatives, but also to generate a
forum in which cutting edge technologies, ideas and discoveries can be freely exchanged to stimulate new
research. The Specific Aim for this interdisciplinary meeting is to bring together a diverse community of clinicians
and scientists engaged in the care of patients with these rare disorders and discovery of possible avenues to
new, safer and more effective treatments. The 2 keynote speakers, 12 invited speakers and 14 senior discussion
leaders represent world leaders with vast knowledge and cutting-edge discoveries in their respective fields. This
conference will provide education to everyone and stimulate development of young investigators with inclusion
of 8 short talks and 10 flash talks selected from abstracts. Significantly, the environment and time set aside for
formal and informal discussion will generate a forum in which cutting edge technologies, ideas and discoveries
can be freely exchanged, stimulating new ideas and collaborations. Most importantly, this forum will provide the
opportunity for academics, industry representatives, patients and their families to interact and learn from each
other.

Public health relevance
PROJECT NARRATIVE Focusing a scientific meeting on pediatric cholestatic liver disease has the potential of enhancing progress in the treatment of patients with biliary atresia, Alagille syndrome (ALGS), Progressive Familial Intrahepatic Cholestasis (PFIC) and Primary Sclerosing Cholangitis (PSC) and other disorders. This scientific meeting will bring together 1) clinicians that treat patients with pediatric cholestatic liver diseases, 2) investigators that focus on mechanistic aspects of bile duct development, hepatocyte canalicular development, cholestasis and cholangiopathies, 3) industry partners interested in the rare disease space, and 4) patients, families, caretakers, and patient advocates. Our goal is to not only disseminate cutting edge information to patients, advocates, clinicians, scientists and industry representatives, but also to generate a forum in which cutting edge technologies, ideas and discoveries can be freely exchanged to stimulate new research.